Vascularized liver on-a-chip modeling cellular and humoral rejection of allografts

PROJECT SUMMARY
Organ transplantation remains the best and most cost-effective clinical solution for end-stage organ failure;
however, it comes with the burden of lifelong immunosuppression (IS). Although effective in preventing allograft
rejection, immunosuppressive drugs have numerous side effects that negatively impact transplant recipients’
quality of life, including increased susceptibility to infections, increased cancer and heart disease incidence, and
potential kidney damage. Therefore, several preclinical and clinical studies have tested methods designed to
induce transplantation tolerance without lifelong IS. Still, the mechanisms of allograft tolerance are not fully
elucidated. Despite significant advances in the induction of tolerogenesis in classical preclinical models, these
models poorly recapitulate the immune responses in patients. Various innovative human organ-on-a-chip (OoC)
models mimicking in vivo organ structures and functions have been developed, but they have never been used
to model allograft rejection. Therefore, the overarching goal of this proposal is to develop a functional OoC
platform for studying the mechanisms of immune tolerance by modeling allograft rejection. Liver
transplants are more tolerated than transplantation of other solid organs and occasionally show spontaneous
tolerance, suggesting that it would be the ideal in vitro model to study tolerance. Modeling liver allograft rejection
on-a-chip requires a microfluidic device that mimics the physiological function of in vivo liver tissues, including a
microvasculature. The endothelium is a crucial determinant in allograft rejection mechanisms because the
donor’s endothelium is the first contact site with the recipient’s immune system. Despite recent OoC models
including microvasculatures, no vascularized liver-on-a-chip (vLoC) platforms
featuring perfusable organoids
have been established to study T cell extravasation, migration, and infiltration into primary liver organoids. To
bridge this gap, we propose to develop a functional vLoC platform that models T cell-mediated rejection (TCMR)
and antibody-mediated rejection (ABMR). The purpose is to demonstrate that not all HLA mismatches (MM)
and donor-specific HLA antibodies (DSA) are equally able to induce allograft rejection. First, we will
develop a microfluidic-based device in which
human liver organoids, blood-derived endothelial cells progenitors,
and fibroblasts embedded in fibrin will be co-cultured to generate vascularized and perfusable liver organoids.
Then, we will model allograft rejection by perfusing allogeneic T cells or anti-HLA antibodies through the vLoC
model. TCMR and ABMR markers will be assessed and correlated with
the different physicochemical
characteristics of HLA MM and DSA.
This novel platform can significantly impact transplant immunology research
while accelerating the understanding of transplant tolerance and increasing the translation of novel tolerance
induction protocols and regimens to the clinics.

Public health relevance
PROJECT NARRATIVE Despite the tremendous advancement in organ-on-a-chip technologies, liver allograft rejection on-a-chip models have not been developed. Therefore, the overarching goal of this proposal is to engineer a vascularized liver- on-a-chip model comprised of multicellular organotypic microstructures that will recapitulate the pathophysiology of cellular and humoral rejection of liver allografts. Our goal is to offer a novel platform for studying transplant immunology, particularly the kinetics of donor-recipient interactions leading to rejection or tolerance.